Head-to-head comparisons of high-performance plasma phospho-tau epitopes for the detection of Alzheimer's disease

Project Summary/Abstract
Recent studies suggest that plasma assays for phosphorylated tau protein at threonine 231 (p-tau231), threonine
181 (p-tau181), and threonine 217 (p-tau217) are highly associated with both brain amyloid-beta (Ab) and tau
pathologies and identify the spectrum of Alzheimer’s disease (AD) with high accuracy. These studies suggest
that these simple blood tests for tau phosphorylation offer an unprecedented advance for the diagnosis of AD,
bypassing the need for additional biomarkers, including Ab. Plasma p-tau biomarkers have the potential to be
incorporated in clinical practice as a rapid screening test to confirm or rule out AD and to guide management of
patients with cognitive symptoms. Furthermore, this technology has immediate applications for diagnosis and
recruitment in clinical trials and may serve as a tool for monitoring the effects of drug candidates targeting tau
pathology. However, preliminary evidence suggests that the different plasma p-tau epitopes may differ widely in
sensitivity and specificity to detect AD, depending on the disease's stage at which they are quantified. Thus, a
well-powered study measuring p-tau231, p-tau181, and p-tau217 epitopes in the same subjects’ plasma samples
across the AD spectrum has the potential to elucidate the advantages and limitations of using each of the plasma
p-tau epitopes. This study can also clarify whether the quantification of more than one plasma p-tau epitope can
provide complementary information compared to the quantification of a single assay. Understanding the inherent
characteristics of each plasma p-tau epitope to detect the AD continuum can be crucial in interpreting conflicting
results from studies using the different epitopes that will likely emerge in the coming years. Here, we propose a
non-randomized observational biomarker study measuring p-tau231, p-tau181, and p-tau217, Ab, neurofilament
light chain, and total tau in stored plasma samples from 1,400 individuals across the AD spectrum, characterized
with positron emission tomography (PET) tau and Ab scans, enrolled in well-established cohorts of aging and
AD. All individuals will be assessed at baseline, 1-year, and 2-year follow-up visits. In this study, we aim (1) to
compare the performance of plasma p-tau epitopes to identify early and late depositions of Ab and tau proteins
measured by PET. (2) To compare the performance of plasma p-tau epitopes for the diagnosis of the AD
spectrum. (3) To compare the performance of baseline plasma p-tau epitopes concentrations to investigate
longitudinal cognitive deterioration. (4) To compare the performance of longitudinal changes in plasma
biomarkers for use in clinical trials and their associations with longitudinal changes in PET biomarkers. The
results generated in our study will have an impact on the design of several future biomarker programs, shedding
light on the performance of the plasma p-tau231, p-tau181, and p-tau217 epitopes for numerous applications in
research, clinical trials, and clinical practice.

Public health relevance
Project Narrative Three plasma phosphorylated tau epitopes (p-tau231, p-tau181, p-tau217) have recently emerged as important tools to study Alzheimer’s disease (AD) pathophysiology. However, the difference in performance between these epitopes to identify the AD continuum is poorly understood, making it difficult for the field to choose the plasma p-tau epitope or combination of epitopes that will advance for widespread use in clinical trials and practice. We will measure the p-tau231, p-tau181, p-tau217 assays in longitudinally collected plasma samples, with associated positron emission tomography tau and amyloid-beta, from individuals across the AD spectrum to elucidate the performance of each p-tau epitope to use in research and clinical settings.